Personalized Mobile Intervention to Reduce Exposure to Endocrine Disrupting Chemicals (EDCs) in Women of Child-Bearing Age and their Partners

Project Summary/Abstract
Exposures to endocrine disrupting chemicals (EDCs) have been linked to chronic diseases and
conditions including breast cancer, metabolic syndrome, diabetes, and infertility. Timing of exposure, especially
during pregnancy, may have a lifelong impact on the fetus, including neurodevelopmental problems and
asthma. However, there have been no tools to allow those in the preconception, conception, and pregnancy
stages to assess EDC exposures to ensure a healthy pregnancy and normal child development.
Million Marker (MM) was born to fill this need. MM is a precision health company, built by a team of
multidisciplinary scientists who are trained in environmental epidemiology, toxicology, analytical chemistry,
biostatistics, data engineering, and business. Our missions are to crowdsource and scale the biomonitoring of
environmental chemicals and provide actionable results to consumers in a timely manner in order to empower
individuals to proactively assess, track, and reduce their harmful environmental exposures. Starting with a few
biomarkers of common EDCs, our ultimate vision is to discover all possible (“a million”) biomarkers of harmful
exposures to inform and improve individual health outcomes and advance precision medicine.
Less than a year after it was founded, Million Marker developed and sold our first product–a mail-in
urine test for BPA and phthalates–and successfully helped users reduce their exposures through personalized
intervention plans. Customers are able to order a test kit online, receive the test kit via mail, take a
comprehensive exposure survey (via the Million Marker app), send back their samples via mail, view their
personalized reports with tailored product recommendations through a secure online portal, make lifestyle
changes to reduce their exposures, and retest to monitor their progress. Our initial target audience are
individuals of reproductive age, due to the vulnerability pregnancy and preconception to EDC exposures.
However, it is unclear to what extent the MM platform educates, motivates, and ultimately reduces EDC
exposure in individuals in this age range.
Therefore, the aims of the current proposal are to 1) test and validate a this first-of-its-kind mobile EDC
reduction program in a prospective longitudinal cohort intervention trial; 2) assess changes in participants’
environmental health literacy, attitudes, knowledge, and behaviors after using MM’s products and services; and
3) evaluate the MM app and platform usability to improve the user experience. Validating this population with
our program is a step towards these types of future studies. At the conclusion of the project, we will be
well-positioned to begin Phase II and will scale the EDCs testing and personalized intervention plan to fertility
clinics and the general public.

Public health relevance
Public Health Relevance Statement There are no current tools or services available that allow people of reproductive age to understand their personal environmental chemical exposures in order to optimize their pregnancy and childs’ development by changing their lifestyle choices. This work aims to validate our current EDC reduction intervention program (the Million Marker Detect and Detox kit), assess the program’s influence on environmental health knowledge and behavior, and improve the program’s ease of use. Validation of this program is necessary for the further development of a scalable personalized mobile intervention program that can be readily disseminated and commercialized to help customers reduce exposures to EDCs. Completion of this proposal will allow Million Marker to offer improved EDC testing and intervention to those who are or seeking to become pregnant, as well as the general public. This will improve birth outcomes, child health, and public health.